Objective, MRI biomarkers for pre-symptomatic detection of autism spectrum disorder at 6 months old: commercial software development and optimization

There are no changes to the Project Summary/Abstract. An attachment was required to avoid a submission error.

Public health relevance
There are no changes to the Project Narrative. An attachment was required to avoid a submission error.